Knowledge Warding Against Toxin Levels, Administrative Core

PROJECT SUMMARY / ABSTRACT
The Administrative Core of the Knowledge Warding Against Toxin Levels Center for Oceans and Human
Health will be run by the government of Sitka Tribe of Alaska, a federally recognized tribe. The current Director
of the Resource Protection Division of Sitka Tribe of Alaska will be the Director of the proposed Center, and the
Finance Director for Sitka Tribe of Alaska, will be the Business Manager of the proposed Center. The Center
Co-Director is an environmental epidemiologist in academia. The purpose of the Administrative Core will be to
provide oversight, guidance, and direction to all the Projects and other Cores. Specifically, the Administrative
Core will (1) conduct managerial tasks necessary for success of the Center; (2) implement inclusive
community-building and mentoring tasks for Center success; and (3) contribute to the success of the broader
Oceans and Human Health community through education, dissemination, and engagement activities with other
members of the Oceans and Human Health community.